Children’s Cardiovascular Health in a Changing Climate: The Impacts of Extreme Heat and Wildfire Smoke

PROJECT ABSTRACT
Climate change is rapidly intensifying, and climate-related hazards and environmental exposures are expected
to significantly impact multiple facets of child health and development. Over the last decade, the US has
experienced the highest temperatures on record and more extreme heat events, while at the same time, wildfires
have increased in severity, frequency, intensity, and extent, due to our changing climate. As these trends are
projected to increase, the impacts of climate-related exposures on children’s health remain largely unknown.
Exposure to heat stress and wildfire smoke are emerging climate-related threats that have been strongly linked
to adverse cardiovascular health outcomes and mortality in adults. Given that childhood is a critical period in
determining life-long cardiovascular health, and children are uniquely sensitive to environmental insults, it is
crucial to develop a greater understanding of the cardiovascular impacts of climate-related extreme heat and
wildfire smoke, particularly during sensitive periods of development. Further, climate-related exposures often co-
occur and evidence suggests that the combined impacts of heat stress and wildfires may heighten the effects of
each of these exposures on cardiovascular health, thus considering their cumulative effects is important to fully
capture the extent of their likely impacts as climate change accelerates. Lastly, evaluating the efficacy of
household and community adaptation strategies at buffering those health effects in children may provide further
insight into intervention opportunities to protect the most vulnerable. In this proposal, we will investigate whether
greater individual and combined exposures to heat stress and wildfire smoke over the life course and during
sensitive developmental windows in pregnancy and childhood are associated with poorer cardiovascular health
profiles in mid-childhood. We will leverage the MADRES prospective cohort of predominantly Hispanic, lower-
income mother-child pairs to annually evaluate children between ages 6 to 9 years, using a comprehensive set
of cardiovascular health measures, including blood pressure, pulse wave velocity, resting heart rate, blood lipids
and urinary biomarkers of oxidative stress. We will employ novel statistical modeling methods to evaluate
combined exposures during sensitive developmental windows, as well as the role of multi-faceted adaptation
strategies, and conversely vulnerabilities, at the household (air conditioning, filtration) and community levels
(climate and social vulnerability indices, urban heat islands, tree cover, cooling centers, etc.) in modifying the
impacts of climate-related exposures on child cardiovascular health. This work will inform targeted interventions
to reduce cardiovascular health impacts of heat stress and wildfire exposures, increase adaptive capacity, and
protect long term cardiovascular health among children as climate change intensifies.

Public health relevance
PROJECT NARRATIVE Childhood is a critical period in determining life-long cardiovascular health, but the impacts of climate-related factors have not been investigated in this context. Our proposal will employ novel statistical methods to develop a greater understanding of the cardiovascular impacts of individual and combined exposures to extreme heat and wildfires during sensitive periods of development and evaluate the ability of multi-faceted household and community adaptation strategies to reduce adverse effects on child health. Our work will inform targeted interventions to protect health and provide real-life actionable evidence to increase climate adaptive capacity and resilience among children living in disadvantaged urban areas.